Administrative Core

The purpose of the Administrative Core is to facilitate the research program outlined in this proposal. To this end, it will: [unreadable] Provide centralized communication with all participants in the program [unreadable] Organize and convene monthly meetings of the project Pis and core directors [unreadable] Organize the semi-annual meetings of the Internal Advisory Committee [unreadable] Organize the annual meeting of the External Advisory Committee [unreadable] Coordinate annual progress reports to the NIND